Functional Genomic Core

The Functional Genomics (FG) shared resource supports Duke Cancer Institute investigators by providing
a broad range of services to facilitate the application of functional genomics and high-throughput screening
technologies to the study of cancer. Through investments in CRISPR, RNAi, Open Reading Frame (ORF)
and compound collections, as well as high-throughput screening infrastructure, we have assembled stateof-
the-art technological platforms for functional studies in both high-and low-throughput applications. The
FG provides expertise and assistance in developing and implementing genetic screens in arrayed or pooled
format, as well as custom services for the creation of individual knockout, knockin or overexpression cellular
models. In addition, FG enables screening of varied compound collections with either cell-based or
biochemical assays for chemical genetic or drug discovery studies. FG also provides access to advanced
instrumentation for screen-related or standalone assays, including multimodal plate readers and a highcontent
screening (HCS) system for image-based analysis. Finally, the FG is dedicated to developing and
adapting new techniques and reagents to better support the needs of DCI investigators, enabling them to
keep pace with the rapidly evolving field of functional genomics.
In 2022, Functional Genomics provided services to 61 DCI investigators, 67% of all users, and represented
6 DCI Research Programs. Use of the shared resource by DCI members contributed to 39 publications over
the current project period, demonstrating the value of services offered by this shared resource. The FG
shared resource is primarily supported by cost recovery through service fees, with additional institutional
support to subsidize operating costs.